Molecular Markers for Tumors Associated with Extrachromosomal HPV

3URMHFW 6XPPDU\
In the classical paradigm for cervical cancer, keratinocytes are infected with high-risk HPV (HR-HPV)
genomes which become integrated (“iHPV”) into human chromosomes, and facilitate progression to invasive
cancer. However, the concept of HPV integration is not routinely used in clinical practice. Intriguingly, we and
others have shown that at least 25% of HPV-positive (HPV+) cancers harbor only “extrachromosomal” HPV
(“eHPV”), and there are reports of “hybrid” tumors with both eHPV and iHPV. We have also shown that there is
no difference in the distribution of clinical stage between patients with eHPV versus iHPV tumors, even though
patients with eHPV tumors have better clinical outcomes. Based on this, we posit that eHPV and iHPV tumors
have distinct molecular drivers and may require different treatment strategies.
Investigation of novel diagnostic and therapeutic strategies in cervical cancer remains highly significant
despite the advances in screening and vaccination. The successes of these prevention programs in the “West”
have not been replicated in resource-poor countries with the greatest disease burden, and even in the United
States, disparities in vaccine uptake still exist with millions still at risk of developing cervical cancer.
We were the first to discover r
ecurrent somatic ERK2-E322K mutations in primary cancers (8% o
f
cervical cancer). We have now shown that ERK2-E322K mutations are 9 times mo
re likely to occur in eHPV
tumors compared with iHPV tumors. We have also identified specific viral spliced transcripts (VSTs) that
distinguish eHPV and iHPV primary HPV16-positive cervical tumors, and we have shown using VSTs that the
expression of HPV E5, which is known to promote angiogenesis, is a hallmark of eHPV status.
Our overall hypotheses are that eHPV-tumors and iHPV-tumors have distinct host and viral genomic
classification markers, that patients with eHPV tumors respond better to therapy with the angiogenesis inhibitor
bevacizumab than those with iHPV tumors, and that ERK2-E322K mutation enhances the growth of eHPV
tumors more than iHPV tumors. Our specific aims to: (i) characterize host molecular markers that distinguish
eHPV-tumors from iHPV-tumors, (ii) investigate the diagnostic and therapeutic utility of HPV viral spliced
transcripts in cervical cancer, and (iii) investigate the effect of ERK2E322K mutation on the growth of eHPV
versus iHPV tumors.
We expect our research contribution to be significant and impactful for patient diagnosis and treatment.
We will p. rovide translational utility for HPV integration (or the lack thereof) by identifying host and viral markers
for the classification of eHPV and iHPV tumors, and for treatment-related patient stratification.

Public health relevance
Project Narrative Infection with human papillomaviruses (HPV) has been associated with cancers of the cervix, head and neck and the anogenital organs, and these cancers account for at least 5% of all cancers worldwide. In this study, we will develop a new way to stratify these cancers so that we can discover the underlying processes that distinguish the patients who will respond to certain treatments and have good prognosis, from patients whose tumors will not respond and instead progress rapidly. We expect our contribution to be significant because it will tremendously improve our understanding of how to better prevent, diagnose and treat cervical cancer and other HPV-associated cancers.